Unraveling the Mechanisms of Opioid-Induced Airway Constriction: A Path towards Novel Therapeutics for Opioid Overdose

PROJECT SUMMARY
This career development award will allow Dr. Nicholas Burgraff to establish an independent research career
dedicated to understanding the neurophysiological control of airway function and its intricate
interactions within neural networks that regulate respiration, with a pivotal focus on how various
pharmaceuticals, notably opioids, can disrupt these systems. This line of research is crucial as it addresses how
drugs may inadvertently contribute to potentially life-threatening complications like respiratory depression. The
training plan and research strategy outlined in this proposal, combined with Dr. Burgraff's experience in
translational physiology, respiration, and rhythm generation, positions him exceptionally well for success in this
endeavor. The primary sites of focus in this research are the Dorsal Motor Nucleus of the Vagus, Nucleus Tractus
Solitarius, and Nucleus Ambiguus, areas with significant influences on airway smooth muscle control and the
balance of autonomic regulation. We hypothesize that fentanyl disrupts this balance, favoring parasympathetic
dominance that leads to airway constriction. Additionally, the study aims to establish dual-action treatments
targeting both this constriction and rhythm disruptions without reversing opioid binding, offering a new paradigm
in opioid overdose interventions. This project will expand Dr. Burgraff’s prior training in electrophysiology and
whole animal physiology by incorporating cutting-edge techniques including retrograde viral tracing,
immunohistochemistry, optogenetics, and high-density neural recordings. Merging these methodologies will
allow Dr. Burgraff to leverage a multi-level approach to investigate the functional dynamics of fentanyl on
neuronal circuits controlling airway constriction and assess counteractive strategies. Building upon Dr. Burgraff's
preliminary results, the proposed research will pave the way for developing effective therapeutic strategies that
complement or replace conventional opioid reversal strategies. By shedding light on the specific neural circuits
and autonomic mechanisms underlying fentanyl-induced airway constriction, this project holds the potential to
significantly improve patient safety and outcomes in various medical scenarios where opioids are used, from
acute pain to long-term opioid therapy. This investigation thus aligns seamlessly with Dr. Burgraff's career
objectives, his pursuit of R01 funding, and his commitment to advancing the understanding and management of
complications associated with opioid use. To assist Dr. Burgraff in accomplishing the research and career
development objectives of this proposal, he will receive strong mentorship from Dr. Nino Ramirez, a distinguished
figure in respiratory rhythm generation with an impressive track record in mentorship. He will also be supported
by an advisory committee of established professors and attending physicians, all with expertise in the techniques
and translational relevancies that are integral to this proposal. With full institutional support and the additional
training, mentorship, and experience that this grant will provide, Dr. Burgraff will be positioned to successfully
compete for R01-funding and establish a high-impact independent research program in this critical area of study.

Public health relevance
PROJECT NARRATIVE This project aims to investigate the neural mechanisms of fentanyl-induced respiratory depression, specifically focusing on airway constriction and rhythmic disruptions. The project proposes the development of dual-action treatments that address these issues without reversing the opioid's effect, offering a new approach to combating opioid overdoses. Using a combination of cutting-edge techniques like in-vitro and in-vivo electrophysiology, optogenetics, high-density neuronal network analysis, and viral-based manipulation, we aspire to provide significant breakthroughs in our understanding and treatment of opioid-induced respiratory depression.